Novel Model for HIV Latency in Primary Memory T Cells

DESCRIPTION (provided by applicant): The long-term persistence of HIV in a latent state in memory T cells in patients treated with HAART prevents the eradication of HIV and forces patients to remain on HAART for their whole life. While the transcriptional regulation of HIV has been extensively studied in transformed cell lines, our understanding of how latent HIV infection occurs in primary memory CD4 T lymphocytes is rudimentary. The purpose of this application is to develop new single cell technology to examine the transcriptional status of HIV in single primary lymphoid cells over time after an infection in vitro. These studies will bridge the two research fields of human immunology and HIV molecular virology. Understanding HIV latency in primary lymphocytes may lead to the identification of cellular proteins that control the entry of HIV in latency, the maintenance of latency or its reactivation. Such cellular targets could represent new avenues for the treatment of HIV/AIDS among drug abusers and possibly lead to the eradication of infection. I propose to use a novel live cell, time-lapse fluorescence microscopy combined with cell trapping via microfluidic chips and the use of HIV expressing recombinant fluorescent protein (destabilized GFP) to study the kinetics of HIV transcription at the single cell level. This novel technique will allow the fate of HIV expression to be followed in live individual cells over time. Human lymphoid cells will be activated in vitro, infected with an HIV expressing a fluorescent protein, activation signals will be removed and HIV transcription will be followed over time. We anticipate that HIV transcription will be restricted in a subset of cells returning to quiescence. The time separating removal of activation signal to infection is likely to be critical in allowing infection to proceed until HIV integration while restricting HIV transcriptional activation. The nature of the activation signal could also prove critical. Experiment will eventu

Public health relevance
Public Health Relevance Statement HIV persists in patients treated with current antiretroviral drugs, including in drug abusers infected with HIV. The virus is able to persist in a state of dormancy, called latency, in specific memory lymphocytes. Because of the long-term persistence of these latently infected lymphocytes, HIV can reactivate, come out of latency, and reinitiate an infection when anti-HIV drugs are interrupted. Latently infected cells therefore are forcing HIV-infected patients, including drug abusers, to be maintained on anti-HIV drugs for their whole life. The goal of this proposal is to study the mechanism of HIV latency in memory lymphocyte cells isolated from humans. We propose to develop a novel approach that will allow us to study rare memory lymphocyte populations directly isolated from normal individuals and to study the fate of HIV infection in single cells. By studying the mechanism used by HIV to establish latency, we hope to be able to devise novel strategies aimed at eliminating latently infected cells. If successful, such strategies might lead to the elimination of latent HIV infection or to a restriction of the latent pool to a size that can be controlled by the immune system in the absence of drug treatment.